Mu-opioid receptors in the habenulo-interpeduncular circuit in opioid dependence

PROJECT SUMMARY
Withdrawal is a major obstacle in overcoming opioid dependence and addiction. Identifying the neural circuits
involved and how opioids modulate their activity is essential for developing new therapeutic strategies. The
medial habenula (MHb) expresses particularly high levels of mu-opioid receptor (MOR) and emerging evidence
implicates the MHb as a hotspot for the physical and affective symptoms of opioid withdrawal and relapse.
Despite this, there is remarkably little information on how MOR signaling influences MHb projection neurons, or
how chronic MOR signaling could induce physiological changes in MHb circuits that contribute to withdrawal.
MHb neurons project principally to the interpeduncular nucleus (IPN) where they can release acetylcholine (ACh)
or glutamate; and some of these neurons can co-release both glutamate and ACh. While cholinergic- and
glutamatergic-defined MHb neurons have been implicated in processes underlying addiction, the respective roles
and relative importance of these co-transmitters remain unclear. Based on prior literature and preliminary data
we posit an important role for glutamate and ACh co-release from MHb to IPN in mediating effects of opioid
dependence, including withdrawal. In this exploratory proposal we aim to test how acute and chronic MOR
activation influences activity in MHb and synaptic transmission in IPN and contributes to opioid dependence.

Public health relevance
PROJECT NARRATIVE Opioid abuse has led to a massive public health crisis; while maintenance therapies can help, additional therapeutic approaches are sorely needed. To develop alternate targets, a more complete understanding of where and how opioids change brain physiology to induce dependence is needed. In this proposal we will study the effects of opioid signaling on an overlooked brain circuit that densely expresses the primary receptor that abused opioids target.